Technology-based Training Tool for an Empirically-Supported Group-Based HIV and STI Prevention Intervention for Juvenile Offenders

Project Summary
Youth under age 18 involved in the criminal justice system are disproportionately minorities and affected by
substance abuse, mental illness, and HIV/STI. Most young offenders are released on community supervision
without the STI, mental health, or substance use screening, diagnosis, and treatment afforded detained youth,
despite similar rates of risk behavior. Their long-term trajectory is poor, the costs to society are high, and lasting
effects on community well-being and individual employment prospects are profound. Altering this trajectory is a
public health priority. Preventing HIV Among Teens (PHAT) Life is an evidence-based program that meets the
need in juvenile justice to address youths' co-morbid health problems. The next––and perhaps most critical––
step in ensuring that this decade-long line of research produces actual, real-world improvements in the lives of
probation youth is to develop a PHAT Life training strategy that is effective, cost-effective, and sustainable within
juvenile justice settings. This private/public collaboration between Oregon Research Behavioral Intervention
Strategies and the University of Illinois at Chicago will leverage existing resources and competencies to create
a commercially viable technology-based training tool for PHAT Life with great potential for sustainability and
cost-effectiveness. Building on SBIR Phase I research, in this Phase II application proposes to use a formative
process to refine, enhance and complete the technology-based training tool to include: (a) an interactive
multimedia web browser and mobile application, (b) dynamic multimedia presentations and interactive queries,
(c) video examples of mock intervention delivery, (d) audio narration along with scripted language, (e) brief
quizzes to ensure comprehension and knowledge acquisition, (f) opportunities to “learn more” by clicking on tabs
for supplemental information, (g) targeted referrals to appendix materials, (h) games to promote engagement,
and (i) other adaptations based on Phase I feedback. The proposed technology-based training tool should be
highly sustainable, because it (a) relies on “indigenous” personnel to deliver the intervention, (b) is likely to prove
cost-effective since we will utilize a technology that can deliver training at scale, and (c) will improve fidelity by
leveraging technology to provide consistent training experiences to para-professionals. We will evaluate the
training tool via a 2-arm RCT with 130 individuals who work with justice-involved youth. All trainees will receive
the technology-based training tool and half will be randomized to receive supervision prior to real-life delivery.
We will evaluate facilitator knowledge and satisfaction, and fidelity to PHAT Life following real-time intervention
delivery. We will assess key implementation outcomes, including cost, feasibility, acceptability and sustainability.
The proposed study is highly significant with strong commercialization opportunities for a scalable training
solution that supports implementation fidelity and program sustainment addressing a key public health
imperative.

Public health relevance
PROJECT NARRATIVE Justice-involved teens are disproportionately minorities and affected by substance abuse, mental illness, and HIV/STI. Evidence-based programs (EBP) are much-needed to address their co-morbid health problems, but uptake of EBPs in the juvenile justice system is challenging since training is often costly in personnel time and effort. The proposed study to complete a technology-based training tool that teaches individuals to deliver PHAT Life, an evidence-based intervention for justice-involved teens, will facilitate broad uptake, dissemination, and implementation while reducing costs typically incurred in in-person group training programs, therefore, making this scalable training solution a support in implementation fidelity and program sustainment as well as having a strong commercialization opportunity and high public health impact.